Career Development and Training Core

CAREER DEVELOPMENT AND TRAINING CORE: PROJECT SUMMARY/ABSTRACT
The NY-CHAMP Career Development and Training Core (CDTC) will serve as a local and regional scientific
career development hub that 1) offers resources and activities to foster cross-disciplinary, cross-sector
collaboration and 2) sets the stage for a highly diverse, highly collaborative network of scientists poised to
advance innovative, community-centered, anti-racist, multi-level solutions for maternal health equity. The CDTC
will draw on the rich institutional resources of Columbia and Cornell University Medical Centers and synergize
with the vast knowledge and assets of our strong community, governmental, hospital, and academic partners to
transform the pipeline of maternal health scientists to be interdisciplinary in approach and committed to
community-centered, health equity, and anti-racism research. In Aim 1, we will transform the maternal health
research culture to create a pipeline of diverse scholars who are committed to community engagement and
expert in interdisciplinary, multi-sector research partnerships. In Aim 2, we will operate as a hub for maternal-
health-focused training opportunities and resources in structural racism, cultural humility, racial allyship, and
diversity, equity, inclusion, and justice. In Aim 3, we will engage early-stage investigator (ESI) NY-CHAMP
Scholars in hands-on training in intervention science that is community-led, anti-racist, and interdisciplinary via
a collaborative, to-be-designed demonstration project. Our training philosophy values co-creation and co-
implementation of methods and interventions informed by, respectful of, and responsive to the needs of the
diverse communities we serve. The CDTC will contribute to the overall goals of the NY-CHAMP Center of
Excellence by grounding scholars in the culture and structural change that is required to foster innovative new
science and sustained community partnerships for research impact on maternal heath equity from the next
generation of researchers.